Disrupted Communication Between Blood Cells and Non-blood Organs as a Mediator of Aging Pathologies

PROJECT SUMMARY:
In this project, we seek to test the hypothesis that age-related perturbation of interorgan communication signals
emanating from the hematopoietic (blood-forming) system may be a common driver of age-associated
dysfunction across the body’s major organ systems. This possibility is based on recent human studies, which
document an unexpected increase in the likelihood of diseases affecting non-blood organs in individuals with
clonally expanded, mutant blood cells. To test our hypothesis, we will apply a novel in vivo gene editing system
to introduce into mouse blood cells specific somatic mutations that are frequently associated with clonal
hematopoiesis in aging humans. Mutations will be induced in situ, in discrete subsets of endogenous blood
cells of otherwise normal young or aging mice, using a lineage-selective, virus-based gene editing system. We
will then monitor these animals over time for the emergence of mutant blood cell clones and of well-
characterized, age-associated pathologies in three different non-hematopoietic organ systems – the skeletal
muscle, heart and brain. Each of these organs shows profound and well-defined alterations with advancing
age, and prior studies demonstrate that aging pathologies that arise in each of these non-blood organs shows
responsiveness to blood-borne (systemic) signals. Our proposed studies also will compare the possible
differential effects of different mutations occurring in distinct target genes, each associated with aging of the
human blood system, and evaluate whether the lineage restriction (cell type) or timing (age of onset) of the
mutagenic event has any impact on subsequent organismal pathology. Finally, we will apply rigorous single
cell sequencing, heterochronic parabiosis and serum analyte assays to uncover the molecular mediators of
aging-relevant blood-to-non-blood organ communication networks. In this way, our experiments will directly
test the hypothesis that age-associated clonal mutagenesis is a mechanistic driver of aging
pathologies that disrupts interorgan communication between the hematopoietic system and other
tissues, identifying the specific cellular contexts and mutagenic events occurring in the aging blood system
that can drive dysfunction in the cardiovascular, neurologic and skeletal muscle systems through cell non-
autonomous signals. Ultimately, the results of these studies will offer new guidance for the clinical
interpretation and management of individuals identified to harbor clonal hematopoiesis, estimated to represent
more than 20% of individuals over the age of 70 (and potentially nearly all individuals who reach very old age)
and important new insights into the significant interorgan communication mechanisms that contribute to aging
and disease.

Public health relevance
PROJECT NARRATIVE: This project will apply a novel in vivo gene editing approach to reveal key mechanistic drivers that perturb blood cell function with age and directly test the relevance of mutations that arise in cells of the blood system and can drive the expansion of individual blood cell clones to age-related dysfunctions in the cardiovascular, neurologic and skeletal muscle systems.